Long Term Outcomes and Cost-Implications of Inequitable Access to AcuteInpatient Rehabilitation

Project Summary
Spinal cord injury (SCI) affects an estimated 294,000 patients in the United States and often occurs in the
setting of trauma. Sequelae of SCI range from impaired sensorimotor function to complete paralysis, leading to
detrimental effects on employment, social integration, and healthcare system utilization. Importantly, neurologic
losses are mitigated by a post-acute care strategy which emphasizes rehabilitative care provided at acute
inpatient rehabilitation facilities (IRFs). Despite the benefits of IRF care for SCI patients, not all patients with
spinal cord injuries are treated at IRFs. Recent work from our group has shown that publicly insured SCI
patients are less likely to receive care at IRFs compared to privately insured patients, even after controlling for
age, injury severity, and comorbidities. The reasons for this finding are unclear. It is unknown to what degree
lack of IRF care for SCI patients increases their long-term morbidity and healthcare utilization, and it is
unknown whether cost-savings from decreased long-term healthcare utilization would justify expanded access
to IRF care. In Aim 1, we will characterize rates of harm associated with SCI, such as pressure ulcers,
urosepsis, and deep venous thrombosis, among patients who received IRF care versus those who did not. In
Aim 2, we will quantify rates of unplanned healthcare resource use, measured in dollar costs of
rehospitalization and emergency department encounters, among SCI patients who received IRF care versus
those who did not. In Aim 3, we will forecast healthcare system costs associated with triaging patients to
appropriate post-acute care rehabilitation and calculate the cost-effectiveness of such a move. The knowledge
gained from this project will increase our understanding of the role of post-acute care on healthcare system
costs and directly inform healthcare policy interventions regarding the post-acute care of trauma patients with
spinal cord injury.

Public health relevance
Project Narrative Patients with traumatic spinal cord injuries (SCI) risk irreversible functional decline if they do not undergo a timely program of supervised rehabilitation at an inpatient rehabilitation facility (IRF). However, recent work published by our group demonstrates that publicly-insured SCI patients are often not triaged to IRFs in comparison to privately-insured peers, even after controlling for risk factors such as age, comorbidities, and injury severity. The study here aims to quantify the economic costs and clinical complications associated with lack of IRF access and uses novel statistical and machine learning methods to predict the cost effectiveness of policy interventions for improving the care of this vulnerable population.